How Bacteroides species coordinate glycogen metabolism and global gene expression to colonize the mammalian intestine

PROJECT SUMMARY
The human gut is colonized by trillions of microbial symbionts that defend against pathogenic invasion, regulate
host immunity, and convert nutrients into host-absorbable metabolites. Gut microbes have evolved adaptations
to conserve energy during colonization and survive in this highly competitive ecological niche. For example,
members of the Bacteroidetes family employ pyrophosphate, a byproduct of DNA, protein, and glycogen
synthesis, to drive central metabolic reactions and conserve nucleotide triphosphate (NTP) pools. Adaptations
such as these contribute to the prevalence of Bacteroidetes, constituting up to half of all bacteria in the human
intestine. Our lab has extensively studied a conserved Bacteroides transcription factor, called Cur, that encodes
products necessary for colonization and regulating T-cell populations in the intestine. For example, the cur-
dependent gene, fusA2, is a unique translation elongation factor that facilitates GTP-independent protein
synthesis, a process that conserves NTPs and is necessary for intestinal fitness. Furthermore, Cur is directly
responsible for the transcription of BT4295, an outer membrane protein that induces T-cell differentiation.
We have previously demonstrated that the abundant dietary sugars, glucose and fructose, dominantly inhibit Cur
activity. I have recently established that these simple sugars inhibit Cur via hierarchically governed ATP- and
pyrophosphate (PPi)-dependent fructose bisphosphate (FBP) biosynthetic pathways. Remarkably, the canonical
ATP-dependent glycolytic pathway is dispensable for in vitro growth and only necessary to control Cur during in
vivo colonization because PPi-dependent enzymes are primarily responsible for the glycolytic load. These
findings demonstrate that the role of ATP-dependent FBP synthesis is to regulate Cur during intestinal
colonization, rather than producing energy equivalents via glycolysis; however, the mechanism by which FBP
governs Cur activity has not been established. Other members of the Bacteroides family require FBP to
synthesize intracellular glycogen, a process that is necessary for (i) the utilization of cur-dependent, but not -
independent, sugars, (ii) Cur activation during carbon limitation, and (iii) fitness in a murine intestine. Collectively,
the preliminary findings suggest that FBP and glycogen biosynthetic pathways form a cyclical regulatory pathway
that controls Cur based on nutrient availability in the intestine.
Therefore, I hypothesize that FBP governs Cur activity by regulating glycogen metabolism in response
to intestinal nutrient availability. In Aim 1.1, I will investigate the role of FBP in promoting glycogenesis in Bt
using an FBP-conjugated affinity resin coupled with enzymatic assays. In Aim 1.2, I will identify glycogenic genes
that govern Cur activity during nutrient limitation by engineering Bt mutants and measuring effects on cur-
dependent genes. In Aim 2, I will elucidate the signal that is produced by glycogen metabolism during nutrient
limitation using a recombinant, affinity-tagged Cur protein to capture endogenous metabolites.

Public health relevance
PROJECT NARRATIVE The intestinal microbiota plays a crucial role in promoting human development and maintaining gut health. Therefore, it is necessary to investigate adaptations that allow bacteria to compete for a limited supply of nutrients in the crowded gut microbiome. In this study, I will investigate how the prominent gut phylum, Bacteroides, uses glycogen as a metabolic sensor of carbon availability to regulate the global transcription factor, Cur, which is necessary for intestinal fitness and directly transcribes products that benefit the host.